Animal Services Core

PROJECT SUMMARY: ANIMAL SERVICES CORE
The Animal Services Core is structured to meet the evolving needs of investigators for translational research
by providing resources to develop experimental animal models of ocular diseases and test the delivery and
efficacy of new therapeutic agents. The goals are: 1) to provide expert assistance and oversight in the
management of transgenic and gene knockout/knockin animal colonies, including their genotyping; 2) to make
available the use of animal facilities and equipment, provide guidance in their utilization, and supervise the
performance of animal procedures and tissue harvesting; 3) to make available equipment for development and
generation of animal models of ocular diseases and pathologic eye conditions; 4) to provide assistance in
imaging of live animals; 5) to serve as a liaison between investigators and the University's animal facilities and
services.

Public health relevance
NARRATIVE: ANIMAL SERVICES CORE The Animal Services Core provides shared equipment and technical staff to develop experimental animal models and test new regenerative therapies in translational vision science research.